Investigating the role of melanoma-adipocyte cell junctions in heterotypic communication and tumor progression

PROJECT SUMMARY
Melanoma is the most lethal skin cancer. Few treatment options exist for patients with metastatic disease.
Upon tumorigenesis, melanoma cells invade into dermal and subcutaneous tissues and then eventually
metastasize to distant organs, encountering and interacting with various microenvironmental cell types. The
tumor microenvironment plays a significant role in melanoma progression. Lipid-laden cells called adipocytes
are located in the subcutaneous layer of the skin. Recent work from our lab demonstrated that adipocytes
serve as a source of fatty acids that fuel melanoma growth and invasion. Although melanoma tumors are often
in direct contact with adipocytes, the mechanism of melanoma-adipocyte communication is unclear. Our
preliminary data identify the presence of gap junctions between melanoma cells and adipocytes. These data
point to Adipocyte Cell Adhesion Molecule (ACAM) as a potential mediator of melanoma-adipocyte adhesion.
In Aim 1, we will investigate the mechanism of melanoma-adipocyte adhesion and its role in tumor
progression. ACAM mediates cell-cell adhesion through homophilic binding. Our own data show that ACAM is
upregulated in melanoma cells that are co-cultured with adipocytes. Loss of ACAM in melanoma cells
abrogates gap junctional communication with adipocytes. We hypothesize that ACAM is a key regulator of
melanoma-adipocyte contact and communication. Using human melanoma cell lines and adipocytes in a
co-culture system, we will identify changes in melanoma-adipocyte adhesion and cell-cell communication upon
knock out of ACAM. We will engineer adipocyte-restricted ACAM knockout zebrafish to delineate the effects of
adipocyte-specific ACAM loss on tumor progression. In Aim 2, we will elucidate the mechanism and
functional consequences of melanoma-adipocyte gap junctions. Gap junctions mediate the transfer of
ions, small metabolites, and secondary messengers such as cAMP, a key activator of lipolysis, between
neighboring cells. We hypothesize that melanoma-adipocyte gap junctions facilitate the direct transfer of
signaling molecules between coupled cells, ultimately activating tumor-promoting pathways such as
lipolysis. To gain insight into the molecular basis for melanoma-adipocyte gap junctions, we will first identify
the connexin(s) composition of these channels. We will also study the role of melanoma-adipocyte gap
junctions in lipolysis and tumor progression using an in vivo zebrafish subcutaneous transplant model. By
investigating how melanoma cells interact with adjacent adipocytes, we seek to delineate the impact of
adipocytes on tumor progression and identify novel therapeutic targets of the tumor microenvironment.

Public health relevance
PROJECT NARRATIVE Interactions between melanoma cells and the tumor microenvironment have important implications for tumor progression and metastasis. Melanoma cells and adipocytes closely interact at the tumor-fat interface, but the mechanism of melanoma-adipocyte communication is poorly understood. In this study, we aim to determine how melanoma cells and adipocytes interact and the role of this crosstalk in melanoma progression.